Role of IL-6 trans signaling in atherosclerosis development and late-stage pathogenesis

Atherosclerosis is a chronic inflammatory disease whose clinical complications, including myocardial infarction (MI)
and stroke, are the leading causes of death worldwide. Given the compelling evidence that inflammation plays a key
role in development of atherosclerosis, the expectation was that lipid lowering, combined with global suppression of
inflammation, would markedly reduce late-stage disease complications. The CANTOS clinical trial testing an
IL1 antibody, Canakinumab, provided compelling evidence validating the inflammation hypothesis. However, the
drug failed to get FDA approval due to it having modest beneficial effects including no reduction in cardiovascular
death (CVD) but a 40% increase in death due to lethal infection. The reasons for the disappointing results of CANTOS
are complex but likely were due in part to IL1β antibody treatment inhibiting not only detrimental pro-inflammatory
responses, but also evolutionarily conserved beneficial inflammatory processes necessary for injury-repair including
formation and maintenance of the ACTA2+ fibrous cap. Consistent with this possibility, we (Gomez et al., 2018 Nature
Medicine) previously showed that IL1 receptor signaling in smooth muscle cells (SMC) is required for their investment
and retention in the protective fibrous cap, and that treatment of SMC lineage tracing Apoe-/- mice with advanced
lesions for 8-weeks with a murine IL1 antibody resulted in multiple detrimental effects including a >50% reduction in
SMC number and collagen content within the fibrous cap. Our study is just one of many examples illustrating how
pro-inflammatory signaling may have beneficial or detrimental effects on the pathogenesis of atherosclerosis. As
such, there is a need to identify more nuanced approaches for inhibiting the adverse effects of chronic inflammation
without eliminating beneficial functions essential for tissue repair, immune resistance to pathogens, and inflammation
resolution. Studies in this proposal will test the hypothesis that selective inhibition of interleukin 6 (IL-6) trans signaling
alone, rather than inhibition of both trans and classic IL-6 receptor (IL-6R) signaling, is not only preferred to avoid
immuno-deficiencies, but is also required to see optimal atherosclerosis-protective effects because of offsetting
beneficial effects of inhibiting IL-6 trans signaling versus detrimental effects of inhibiting classical IL-6R signaling. We
will test this hypothesis as follows. Aim 1 will determine if IL-6 and IL-6R neutralizing antibodies, which inhibit both
IL-6 classic and trans signaling, versus the IL6/sIL-6R trap sgp130Fc, which selectively inhibits only IL-6 trans
signaling, differentially alter lesion development or pathogenesis including cell-matrix composition and indices of
stability. We will do prevention and late stage intervention studies in our novel SMC-endothelial cell (EC) dual lineage
tracing Apoe-/-mice, as well as our novel delta CT Ldlr-/-mice which develop advanced coronary artery atherosclerosis
and evidence of spontaneous MI. Aim 2 will define the role of IL-6 trans signaling in EC and SMC in atherosclerosis
development and late-stage lesion pathogenesis. Our approach will be to selectively eliminate IL-6 trans signaling in
these cells by EC- or SMC-specific knock out (KO) of the IL-6 cytokine family signal transducer glycoprotein 130
(gp130) (IL6ST in humans) required for IL-6 signaling in cells like EC and SMC that do not express the IL-6R.

Public health relevance
Project Narrative/Relevance: Thromboembolic events secondary to rupture or erosion of advanced atherosclerotic lesions are the underlying cause of most heart attacks or stroke and are the leading cause of death in the United States and worldwide. Whereas there is general agreement that atherosclerosis is a chronic inflammatory disease, multiple large clinical trials of drugs that globally inhibit inflammation have failed to get FDA approval due to them having modest or no beneficial effects on the incidence of a fatal or non-fatal heart attack or stroke, and an increase in lethal infection because patients are immuno-compromised. We postulate that a major reason for the failure of global anti-inflammatory agents is because they inhibit not only detrimental chronic pro-inflammatory responses that exacerbate atherosclerosis, but also evolutionarily conserved beneficial acute inflammatory processes necessary for resistance to infection, resolution of inflammation, and tissue injury-repair processes important for enhancing the stability of atherosclerotic lesions and reducing the chance of rupture or erosion. Studies in this proposal will use novel mouse models and analysis methods to determine if selective inhibition of interleukin- 6 (IL-6) trans signaling, which is believed to be a key mediator of the transition from acute (beneficial) to chronic (detrimental) inflammation, promotes formation of more stable atherosclerotic lesions and a reduced probability of lesion rupture or erosion but without impaired immuno-competence. If so, results would be of major significance in that they would suggest that human clinical trials should focus on testing selective IL-6 trans inhibitors not global inhibitors of IL-6 responses as is currently the case with a recently initiated large Phase 3 clinical trial.